Safety Learning and Plasticity in the Insular Cortex

Project Summary/Abstract Candidate: Dr. John Christianson is a F32-funded research associate with extensive knowledge the neural mechanisms underlying resilience and vulnerability to anxiety and fear behavior. Past research has identified that psychological variables, including behavioral control over stress and safety signals during stress lead to a resilience from stress-induced anxiety. Furthermore, he has identified causal roles for the medial prefrontal cortex and insular cortex, respectively, in these stress-mitigating effects. His immediate goal is to advance his academic and technical skills in order to enact an independent research program studying the neural basis of safety learning and fear inhibition by safety. The K99/R00 proposal is a key component in this pursuit. Career Development Plan: Dr. Christianson’s proposed training activities consist of: 1) training in electrophysiological techniques for the study of neuroplasticity, 2) attendance and participation at scientific meetings in which the scientific content revolves around learning and memory, 3) mentoring and training of undergraduate and graduate students on independent research projects within the sponsors’ laboratories. Environment: The research will be conducted in the University of Colorado’s Psychology & Neuroscience Department and the Institute of Behavioral Genetics. Co-sponsors, Drs Steven Maier and Donald Cooper are established investigators in the fields of stress, learning & memory and neuroplasticity. Both labs have a sufficient extramural funding to support the proposed research and excellent records mentoring postdoctoral fellows. Furthermore, the laboratory space is adequate and equipment state-of-the art. Research: The proposed studies test two complementary hypotheses relating safety learning. Safety learning is a Pavlovian process by which sensory stimuli come to predict the non-occurrence of an aversive event. First: Safety learning occurs in the insular cortex. This will be tested in several ways including i) pharmacological inhibition of insular cortex at the times when a rat is learning or recalling the safety cue, ii.) in vitro whole-cell patch clamp assessment of intrinsic excitability of amygdala-projecting insular cortex neurons and iii.) multiple- electrode assessment of plasticity within insular cortex synapses. Second: Exposure to uncontrollable stress, a laboratory model of posttraumatic stress disorder (PTSD), will interfere with learning and expression of safety signals. This hypothesis will be tested by interpolating uncontrollable stress before or after the safety learning. Together these complementary approaches will lead to a significant advancement in understanding of the neural mechanisms underlying safety and provide a paradigm for studying pathological safety learning as occurs in PTSD.

Public health relevance
Project Narrative: Learning the difference between danger and safety is critical to survival, yet in some psychiatric conditions this process fails. Without veridical detection of safety, someone may express fear or anxiety even when the environmental cues indicate that danger is unlikely. The proposed work tests the hypothesis that the insular cortex is a critical contributor to safety learning and that neuroplastic changes in the insular cortex underlie the storage and recall of safety memory. This work has important implications for the treatment and diagnosis of posttraumatic stress disorder and other conditions that involve heightened fear and anxiety. __SpecificAimsTextDelimiter__ Specific Aims Discrimination between danger & safety is critical to survival & allows the organism to avert threat or exploit environmental resources. Little is known concerning the neural mechanisms underlying safety. This is in part because “safety” is only meaningful in the context of potential danger & procedures for studying safety learning are inherently more complex than danger learning. To learn that a cue indicates safety one must first learn that certain cues predict danger & then that other cues (safety signals) do not. This is achieved in the lab by paring a learned danger cue, one that was previously paired with a shock, with a novel cue, one that will become a safety signal, in the absence of a shock. Once learned, a safety signal predicts the non-occurrence of shock & is a powerful inhibitor of fear [1]. Importantly, failure to distinguish safety from danger has been implicated in the psychopathology of posttraumatic stress disorder (PTSD) [2, 3], a substantial public health concern [4]. Safety signals are active inhibitors of fear & the overall hypothesis is that a safety cue presented during fear will cause inhibition to the circuitry that typically mediates fear expression, the amygdala. The posterior insular cortex is positioned to detect the safety signal & then, via direct amygdala projections, influence fear expression. Since safety signals produce enduring control of behavior, neuroplasticity is expected in this circuit. Incorporating both basic mechanistic studies & a behavioral model of PTSD, the proposed work will advance understanding of the neural machinery underlying safety learning & how traumatic stress influences that circuit. The specific aims are proposed as working hypotheses for simplicity. AIM 1: Safety learning & expression require the posterior insular cortex (IC). A critical role for the posterior insular cortex is hypothesized in safety learning because: anatomically, the IC receives cortical & thalamic sensory [5] input, & projects to lateral, basal & lateral central amygdala [6] structures implicated in fear inhibition [7, 8]. Furthermore, both lesion [9] & temporary inhibition (pilot study) of IC abolish the stress mitigation that occurs when safety signals are provided during stress. In a fear conditioning procedure, rats will be trained to discriminate between a fear-excitatory conditioned stimulus (CS), the danger signal, & an inhibitory stimulus, the safety signal (SS). Using standard systems neuroscience methods, the first sub-Aim (Aim1A) will test whether pharmacological disruption of plasticity in IC interferes with safety learning & whether IC activity is required for recall of the safety signal during a test of fear inhibition. Although the IC is emphasized here, should these studies indicate that IC is not necessary for safety learning/fear inhibition, alternative structures including the dorsal striatum, medial prefrontal cortex & the basolateral amygdala will be explored. The second sub-Aim (Aim1B) deals with the effect of stress on safety. Uncontrollable tailshock is a laboratory stressor that elicits behavior in the rat that resembles some symptoms of PTSD [10]; specifically, anxiety [11], facilitated fear learning & delayed fear extinction [12]. These consequences do not occur when the stressor is controllable & the neural mechanisms underlying these behaviors are known, allowing subsequent mechanistic studies. Prior uncontrollable stress is hypothesized to interfere with later safety learning, thus requiring significantly more training for a safety signal to inhibit fear. Furthermore, uncontrollable stress given after safety signal training is hypothesized to interfere with expression of the safety memory. In other words, after stress a signal that formerly inhibited fear will no longer do so. AIM 2: Safety learning involves neural plasticity. Since safety training produces a lasting memory for the safety signal, it is assumed that neural plasticity in the IC & other regions is required for its long-term storage. This aim will quantify intrinsic, synaptic & structural plasticity in IC superficial & deep layers, and amygdala-projecting IC neurons as a result of safety learning. As occurs in the prefrontal cortex as a result of fear extinction learning [13], plasticity is expected as a consequence of safety training. Consistent with this hypothesis, in Aim 2A we plan to use state-of-the-art electrophysiological techniques to measure changes in the excitability of the IC neurons. Specifically we expect to observe increased excitability in deep layer pyramidal neurons that project to subregions of the amygdala. Some examples of intrinstic changes might include: more positive resting potential (K channel plasticity), more negative action potential threshold & faster rise rate (Na channel plasticity), smaller after hyper-polarization (Ca-activated K channel plasticity), larger after-depolarization (TRPC channel or Ca channel plasticity). Increased excitability would also be reflected in synaptic plasticity. In Aim2B multiple electrode array and patch clamp methods will be used to quantify several forms of synaptic plasticity in layer 2/3 and layer 5 synapses. Finally, in Aim2C structural plasticity (spine density, dendrite characteristics etc) will be assessed by Neurolucida reconstruction of recorded neurons. Before training deposits of a fluorescent retrograde tracer will be made in the lateral and basal amygdala so that pathway-specific trends in plasticity can be characterized. The approach in this aim is to characterize safety-induced plasticity to inform subsequent mechanistic studies that will form a major component of my future independent research.